SUPPORT FOR THE NIH SBIR/STTR APPLICANT ASSISTANCE PROGRAM (AAP) IN SUPPORT OF THE DEPARTMENT OF HEALTH AND HUMAN SERVICES, NATIONAL INSTITUTES OF HEALTH (NIH), NATIONAL CANCER INSTITUTE (NCI), SMALL

SUPPORT FOR THE NIH SBIR/STTR APPLICANT ASSISTANCE PROGRAM (AAP).